Intestinal regulation of exercise performance

SUMMARY
Exercise is an extremely effective lifestyle intervention that dramatically lowers the risk for cardiovascular,
metabolic, neoplastic, chronic inflammatory, and neurodegenerative diseases. Despite these beneficial effects,
the modern human lifestyle is highly sedentary and new approaches to understanding and improving exercise
performance are urgently needed. In this proposal, we will take a new approach and investigate physical activity
through the lens of the gastrointestinal tract. In preliminary work using gnotobiotic mice and microbiota depletion
approaches, we have recently discovered a critical role for the intestinal microbiome in regulating exercise
performance. We found that intestinal microbial colonization contributes to the exercise-induced surge in
dopamine in the brain. Dopamine, in turn, is a major element of the reward and reinforcement centers of the
brain that drive the engagement in physical activity. Importantly, elevating dopamine levels in the striatum of
microbiota-depleted mice restores their exercise performance. This effect of the microbiota on the brain during
exercise is dependent on TRPV1+ afferent sensory neurons. These findings provoke the central hypothesis that
that the microbiome effect on exercise performance is mediated by neuronal gut-brain signaling which regulates
the availability of dopamine in the striatum. We will employ an innovative toolbox at the interface of microbiome
science, exercise physiology, and neuroscience to address three central questions:
(1) Which microbial genes and which intestinal metabolites influence exercise performance? (2) Which
dopamine-sensitive neurons respond to exercise and the microbiome to enhance physical activity? (3) Which
sensory neurons transmit the microbiome-derived gastrointestinal signal to the brain to enhance exercise
performance?
Collectively, these studies will mechanistically define elements of a gut-brain pathway linking the commensal
microbiota, gut-innervating sensory neurons, and striatal activity during exercise. Further, the proposed
experiments will provide important pre-clinical evidence on the therapeutic potential of gastrointestinal
interventions, such as diet and microbial modulation, aimed at enhancing physical activity.

Public health relevance
NARRATIVE Exercise is an extremely efficient lifestyle factor to prevent and reverse metabolic, inflammatory, and neoplastic diseases, but exercise is hard and the regulatory mechanisms driving an individual's ability to exercise remain poorly understood. This proposal explores the impact of the intestinal microbiota on the activity of brain neurons that influence exercise performance. The results of these experiments will enhance our understanding of how exercise performance can be controlled, and possibly enhanced, from the gastrointestinal tract.